Chronic Alcohol and Brain Stress Circuit Response

Project Abstract / Summary
Alcohol use disorder (AUD) is associated with high relapse risk, and so identifying those most vulnerable to
relapse and heavy drinking is critical to improve AUD outcomes. Chronic pain (CP) frequently co-occurs with
AUD and promotes pain-related heavy drinking. Previous work showed significant chronic alcohol-related
neuroadaptations in stress-related neural and neuroendocrine pathways and high craving that predicted heavy
drinking and relapse outcomes. Current preliminary data indicates that AUD patients with CP (AUD+/CP+) and
also AUD-/CP+ drinkers report higher cue-induced craving and greater heavy drinking days (HDD), along with
specific pain-related insula dysregulation that predicts high cue-induced craving and greater HDD. However,
the specific alterations in pain-related neural and biobehavioral circuits that promote pain-related heavy
drinking is not known. Based on this preliminary data and previous research, we hypothesize that specific
alcohol-related insula neuroadaptations promote higher cue-related alcohol craving and greater pain-related
HDD, and that reduction in this specific insula dysregulation and in cue-related alcohol craving with effective
standard behavioral treatment will improve pain-related alcohol heavy drinking outcomes in those with AUD+
and CP+ non-AUD drinkers. In a 2 X 2 experimental design with a prospective clinical outcomes phase, men
and women with AUD, with/without CP, and non-AUD individuals with/without CP will be studied in two related
studies utilizing combined multimethod subjective, neuroendocrine, neural MRI assessments and prospective
alcohol use outcomes. The following specific aims are proposed: Aim 1: To examine chronic alcohol- and
pain- specific subjective (pain, stress, craving), neural and neuroendocrine responses to visual cue blocks
(stress/pain, alcohol, neutral) in AUD (+/-) and CP (+/-) groups. Aim 2: To examine whether specific AUD+ and
CP+ neuroadaptations in primary and secondary predictors are associated with prospective, real-world daily
alcohol craving, pain and alcohol use outcomes. Aim 3: To evaluate changes in primary and secondary
predictors with CBT for AUD and for CP, and whether treatment-related neural, endocrine and subjective
responses during fMRI predict treatment-related improvements in daily pain, craving and alcohol use outcomes
during the 8-week treatment period. Aim 4: To assess the effects of demographic (sex, age, race) and clinical
(trauma, psychiatric history) variables on primary and secondary predictors of AUD and CP comorbidity and on
drinking outcomes. Exploratory Aim: To explore whole brain pain-specific structural gray matter volume
(GMV) and task-based functional connectivity using connectome-based predictive modeling (CPM) at scan 1,
and prediction of changes in pain-related structural GMV and drinking connectomes with CBT treatment.
Successful completion of the proposed aims will identify chronic alcohol-related pain-specific neural, subjective
and neuroendocrine correlates contributing to increased pain-related alcohol use outcomes, that may then be
targeted in treatment development to reduce pain-related drinking outcomes to improve AUD risk and recovery.

Public health relevance
PI: Sinha, Rajita TITLE: Chronic Alcohol and Brain Stress Circuit Response (R01-AA013892-15) PROJECT NARRATIVE There is a current opioid crisis in the US driven by high levels of chronic pain and heavy alcohol intake that alters brain and peripheral pain and stress pathways in ways that promote increased alcohol craving and heavy drinking risk. This project will study men and women with and without alcohol use disorder (AUD) and those with and without chronic pain in an experiment of neural and biobehavioral responses to stress/pain and alcohol cues relative to neutral cues, and also assess if changing those responses with standard behavioral pain and AUD treatment improves clinical pain and craving symptoms and pain-related alcohol use outcomes in AUD. Findings will critically inform development of new interventions to reduce pain-related heavy drinking to improve alcohol use and pain outcomes.